Meninges Specification and Cellular Crosstalk to the Developing Brain

PROJECT SUMMARY
Development of the central nervous system (CNS) requires precise intercellular ‘crosstalk’ between
neural cells and non-neural cells. Fibroblasts in the meninges are a non-neural cell that substantially influences
brain development, in large part via secreted factors that guide neuronal migration and neurogenesis. This is
underscored by significant defects in CNS development observed in mice and humans with mutations in FOXC1,
a transcription factor expressed by meningeal fibroblasts but not any neural cells. However much remains
unknown about how factors from the meninges activate or inhibit molecular signaling pathways in neural cells to
influence developmental processes. Filling these gaps in knowledge would significantly improve our
understanding of the homeostatic function of the meninges and the pathology that occurs in neurodevelopmental
disorders. Foxc1 mutants do not have normal meningeal fibroblasts over the forebrain, have increased apical
progenitor self-renewal and reduced neuron production leading to neocortical lengthening, linked in part to lack
of meninges derived retinoic acid. However, it is not known what aberrant signaling pathways in Foxc1 mutant
apical progenitors promote increased self-renewal and how this is connected to a reduction of meninges derived
factors like retinoic acid. The objective of this proposal is to investigate how meninges derived factors regulate
molecular signaling to control neurogenesis in the neocortex. Using spatial transcriptomics on embryonic Foxc1-
KO tissue sections, I have identified elevated Notch signaling, known to promote stem cell self-renewal, in Foxc1-
KO neocortical progenitors. In Aim 1, I will use global and targeted approaches to inhibit Notch signaling in
Foxc1-KO animals and test if this improves neocortical neurogenesis in these mutants. In Aim 2, I will test is
meningeal derived retinoic acid or other factors produced by the meninges modulate Notch signaling in
neocortical progenitors to promote neurogenesis. Results from this project will provide important insight into
molecular mechanisms for meninges-brain signaling required for normal development.

Public health relevance
PROJECT NARRATIVE Several neurodevelopmental disorders arise from defects in neurogenesis and neuronal migration. Though some work has been done, the underlying processes that contribute to normal neural development and the pathological mechanisms in disease remain not entirely known. This proposal focuses on using advanced bioinformatic analyses and molecular manipulations to understand how the meninges, a protective covering for the central nervous system, regulates brain development, how the failure of meninges formation impacts aberrant brain development and identify potential therapeutic strategies to help patients.